The Role of Nuclear Factor Erythroid 2-related factor 2 in Sarcopenic Obesity

PROJECT SUMMARY/ABSTRACT
Sarcopenic obesity is a debilitating condition that increases the risk of frailty, loss of autonomy, institutionalization,
and death in older adults. Currently, obesity medications and lifestyle/behavioral interventions have limited efficacy
for sarcopenia, worsening quality of life, and healthspan. As such, there is a critical need to identify and develop
treatment strategies for patients with sarcopenic obesity. Reactive oxygen species (ROS) are linked with several
age-related human diseases. Oxidative stress has been implicated as a critical factor contributing to the
development of sarcopenic obesity by mediating the decline in muscular fitness. To this end, genetic manipulation
of redox systems drives oxidative stress, altering mitochondrial integrity and function in aged skeletal muscle.
Oxidative stress also decreases the mitochondrial number and phosphorylation capacity while increasing
mitochondrial DNA mutations, ultimately resulting in organelle apoptosis. The nuclear factor erythroid-related 2
(NRF2) is a primary regulator of antioxidant and redox-regulating protein expression that maintains redox balance
across the lifespan. In fact, NRF2 expression in older adults is decreased and is associated with increased oxidative
stress and damage in skeletal muscle. Therefore, activation of NRF2 is a promising therapeutic approach for
several chronic diseases under oxidative stress and impaired mitochondrial quality control, such as sarcopenic
obesity. This application will examine the role of NRF2 in sarcopenic obesity. The central hypothesis is that NRF2
dictates the mitochondrial quality control signaling, and its disruption exacerbates muscle loss by impairing
mitochondrial turnover and redox balance during sarcopenic obesity. In Aim 1 (K99 phase), I will test whether loss
of NRF2 regulates DRP1-induced mitochondrial fragmentation in skeletal muscle. I will conduct a series of in vitro
loss of function experiments of NRF2 in primary myotubes to assess mitochondrial fission activation and trafficking.
These experiments will contribute to our understanding of whether targeting NRF2 improves muscle function and
mass during sarcopenic obesity by regulating mitochondrial fission. For Aim 2 (R00 phase), I will determine whether
NRF2 is a master regulator of mitochondrial quality control signaling in skeletal muscle during sarcopenic obesity.
Here, we will use aged mice that are normal weight or have obesity with muscle-specific deletion of NRF2 treated
with or without a mitophagic flux inhibitor (Chloroquine). These experiments will identify whether loss of NRF2
blunts mitochondrial quality control, exacerbating oxidative stress in the muscle. This MOSAIC-K99/R00 NIH
Pathway to Independence Award will provide dedicated time and training to learn classic concepts of mitochondrial
biology, skeletal muscle cell culture techniques, and the generation of transgenic mice. These new skills will be
combined with my previous muscle biology skills to facilitate the implementation of an independent study during
the R00 phase. These studies will position me to achieve my long-term goal of directing an extramurally funded
research program that addresses skeletal muscle mitochondrial quality control during aging.

Public health relevance
PROJECT NARRATIVE Sarcopenic obesity is strongly associated with a decline in physical function and less independence in older adults. As such, there is immense value in determining strategies to mitigate sarcopenic obesity to improve the quality of life in older adults. The proposed study will pave the way for novel mechanistic insights and the discovery of new therapeutics for healthspan during aging with obesity.